PEP/PrEP via Pharmacist-Prescribing Implementation (PEPPI)

Project Summary/Abstract
Post-Exposure Prophylaxis (PEP) and Pre-Exposure Prophylaxis (PrEP) therapies are highly effective at
preventing HIV infections; however, uptake and adherence to these therapies remains low, with only 36% of
eligible patients receiving prescriptions.1 With 89% of patients living within five miles of a community
pharmacy and pharmacies being over 20 times more available than other PrEP prescribers across high-
priority areas identified by the Ending the HIV Epidemic initiative,2-3 pharmacists are considered the most
accessible health care provider. This positions community pharmacists well to improve PEP/PrEP access by
providing pharmacist-prescribed PEP/PrEP services. The vast majority of community pharmacists feel
pharmacist-prescribed PEP/PrEP services are important.4-5 and 94% of patients are comfortable receiving
PrEP therapy from a pharmacist.6 However, only between 3% and 11% of community pharmacies in states
allowing pharmacist-prescribed PEP/PrEP services report offering the service.4,7-8
For this project, we will partner with two community organizations, The Source LGBT+ Center and Positively
Aware, and use a community-based participatory approach. Our community partners will provide feedback
on our data collection tools, assist with recruitment, and be informed of our progress and results throughout
Aims 1 and 2.
Phase I (Aims 1A and 1B) will follow the first five steps of the Design Thinking process (empathize, define,
ideate, prototype, and test) to develop a user-informed prototype of the PEPPI software, that will support
implementation of effective and sustainable pharmacist-prescribed PEP/PrEP services.
Phase II (Aim 2) will involve the development and assessment of the PEPPI software in a real-world setting
(i.e. community pharmacies). We will assess the impact of the PEPPI software on 1) implementation of
pharmacist-prescribed PEP/PrEP services and 2) patients' access to care via a single-arm clinical trial. The
clinical trial will have three consecutive phases where pharmacists provide PEP/PrEP services under three
conditions: 1) control (no PEPPI software), 2) Intervention Phase I (PEPPI minimally viable product [MVP]), and
3) Intervention Phase II (enhanced PEPPI software with integrations).
At the conclusion of this project, we will have a market-ready, proven, user-informed PEPPI software
application that will facilitate the implementation of pharmacist-prescribed PEP/PrEP services.

Public health relevance
Project Narrative With only 36% of patients in need of pre-exposure prophylaxis (PrEP) therapy receiving therapy to prevent HIV, improving access to PEP/PrEP is an important public health issue and pharmacists are well-positioned to improve access via pharmacist-prescribed PEP/PrEP services. This proposal unites community pharmacy reproductive health leaders with community partners, The Source LGBT+ Center and Positively Aware, to create a user-informed PEP/PrEP Access via Pharmacist Prescribing Implementation (PEPPI) software application to support implementation of pharmacist-prescribed PEP/PrEP services. Design thinking and community-based participatory approaches will lead development and evaluation, via a clinical trial, of the PEPPI software to ensure the end product is proven, useful, market-ready, and acceptable to both pharmacist and patient end-users.